Funding for Renal/Urothelial trainees and junior investigators at the American Physiology Society Summit ETG Sessions

Abstract
This application requests funding to support the travel expenses of trainees and junior investigators focusing on
renal and urothelial epithelial physiology, to present their research at the Epithelial Transport Group (ETG)
scientific sessions at the American Physiological Society (APS) Summit Meeting 2025. For the past two years
APS has hosted a standalone annual meeting, the APS Summit, a newly formatted experience focused on
innovative and collaborate research, built by physiologists and with a strong emphasis on the training and support
of trainees and new investigators. The goals of ETG / Renal sections and this R13 application strongly
complement APS’s mission to advance the discipline of Physiology, to benefit the community, and to train and
excite the next generation of scientific thought leaders. The APS Summit, and all ETG / Renal sessions will take
place April 24th – 27th, 2025, at the Baltimore Convention Center, MD. The Baltimore Convention Center is
centrally located on the US East Coast and easily accessible by car, rail, and airplane. The Convention Center
is also ADA-compliant with infrastructure for individuals with disabilities and special needs.
The ETG has a longstanding history of promoting interactions among physiologists from diverse backgrounds
who study biological processes in epithelia and encourages trainees and junior investigators to develop research
careers in epithelial biology. Based on prior experience and survey data, trainees consistently view the annual
ETG sessions as a valuable training experience that reinforces their interest in the field and promotes retention
in renal epithelial-centric biomedical research. Thus, we strive to optimize trainee exposure to ETG-related
events by providing travel award support for trainees and junior investigators with limited travel resources. This
application will solely focus on supporting early career researchers focused on KUH-centric related research
areas. The ETG Aims for the meeting are to provide trainees and junior investigators (1) forums to present their
work; (2) excellent state-of-the-art scientific symposium and lectures; (3) opportunities to network with their peers
and more senior scientists in kidney, urothelial and epithelial transport fields.
The 2025 APS Summit agenda includes more than 15 renal / urothelial focused sessions developed by the ETG
and Renal Section. All trainees who submit ETG-based abstracts to the Renal Section will be eligible for travel
awards. The abstracts will be reviewed and scored jointly by members of both the Renal Section and ETG
Steering Committees. The travel awards will be allocated based on merit. Award amounts will be contingent on
the funds that are available. Regardless of the amount; however, the budget incorporates an additional
supplement to awardees with child/family care needs in order to encourage meeting participation by trainees
with primary child/family care responsibilities. This is extended to other non-traditional family support needs. Top
scoring abstracts will be selected for oral presentations in the Hebert Lecture, the Ussing Lecture, and other
Renal/ETG-based sessions. In 2025, these prestigious lectureships will recognize Drs. Edith Hummler (Hebert)
and Alan Verkman (Ussing) for their important contributions to epithelial biology and transport. These mixed
format symposium have proven popular among trainees, as it provides an exciting opportunity for talented early
career physiologists to present their research alongside preeminent scientists in a formal, but collegial setting.
We will continue our extremely popular Young Investigator Epithelial Transport Symposium, which had record
breaking attendance in 2024. This “pre-meeting” will provide additional opportunities for trainees and junior
investigators to orally present their work in a less formal atmosphere, with networking coffee breaks, lunches
and networking sessions. An interactive area framed as “The Hub”, will serve as a meeting point for ETG-related
Renal research, and provide an area for flash-talks, discussions and networking amongst prominent scientists.
This will include the “Meet the Experts” sessions. Given ETG’s commitment to diversity and trainee mentoring,
we believe that the support provided by this application will dovetail with the proposed meeting structure to
enhance career development of early career researchers interested in renal epithelial and urothelial physiology.
Together, this will serve our long-term goal of maintaining the pipeline of epithelial biologists in biomedical
research careers related to the goals of KUH.

Public health relevance
Narrative The purpose of this application is to request travel funds to support trainees who wish to attend and present their research at the American Physiological Society Summit Meeting (on April 24-27th, 2025 in Baltimore, MD) and be part of a unique educational forum for scientists who study renal and urothelial cell function in health and disease. By supporting the travel, education, and development of these promising early career scientists, we hope to expand and diversify the current epithelial biology workforce, ultimately increasing research in the scope of the KUH.